Inferring causality with spatiotemporally stochastic optogenetics

Project Summary
Different cognitive behaviors appear to engage distinct activity patters across brain-wide circuits. This distributed
nature poses a big challenge to understanding which specific activity patterns are causal to different behaviors,
for a few reasons. First, it is technically challenging to perturb neural activity at large scales. Second, the same
brain regions are often involved in disparate cognitive processes, but they appear to interact and communicate
differently depending on behavioral demands. Third, cognitive behaviors do not exist in a vacuum. For example,
you may walk around as you deliberate about your future college, but that action is not required for the decision.
Thus, to truly understand the neural mechanisms of cognition, we need to use circuit perturbations to disentangle
distributed neural activity and interaction patterns that are causal to a behavior from those that are simply
incidental to it. Perturbation methods currently available to neuroscientists cannot accomplish this because they
tend to target one or few regions at a time, and not account for inadvertent changes in the activity of other
interconnected brain regions. To address these challenges, we propose to develop a new set of methodologies
for simultaneous, distributed perturbation of multiple cortical regions using patterned light. Specifically, we will
design a custom apparatus for head-fixed mice that uses a digital micromirror device to deliver spatially
stochastic light patters at cortex-wide scales. This will allow us to borrow concepts from systems identification,
used in electrical engineering and sensory-receptive-field mapping, to infer how large-scale patterns of cortical
activity underlie decision-making behaviors in a data-driven fashion. Specifically, we will first develop an open-
source hardware and software suite to enable these experiments, which will be disseminated to the community
at large. We will then perform proof-of-principle experiments in which we will combine spatially stochastic
optogenetics with reflectance imaging or extracellular electrophysiological recordings using silicon probes, to
estimate distributed cortico-cortical interactions in mice running spontaneously. Finally, we will employ these
approaches in mice performing two ground-truth decision-making tasks in virtual reality, for which we have strong
expectations for the patters of behavioral deficits caused by the perturbation of different cortical areas. These
initial experiments will therefore establish the feasibility and showcase the versatility of our approach. They will
also pave the way for future work using these new methods to probe how distributed cortical interactions support
complex cognitive tasks. I expect the methods we develop will be readily applicable to multiple other behaviors,
neural systems, and model organisms to reveal the elusive causal link between neural interactions and
behavioral function.

Public health relevance
Project Narrative Complex cognitive behaviors are thought to be supported by distributed activity across the brain, but we do not know which exact activity patterns cause specific components of cognitive behavior. This knowledge gap exists partly because most current perturbation methods target single or few brain regions at a time, and do not account for off-target changes in neural activity. Here, we proposed to develop new methods to fill this gap, using simultaneous neural recordings and large-scale spatially stochastic optogenetic perturbation across the mouse dorsal cortex, combined with computational methods, to infer how distributed neural processes generate cognitive behavior.